Modularizing manufacture of PfSPZ vaccines: ookinete production for PfSPZ manufacture in mosquitoes and in vitro

In 2022 WHO called for highly efficacious vaccines against malaria that prevent Plasmodium
falciparum (Pf) infection in > 90% of recipients. Alone among malaria vaccines, Sanaria® PfSPZ (Pf
sporozoite (SPZ)) vaccines have shown > 90% vaccine efficacy (VE) against controlled human
malaria infection and VE against intense field transmission of malaria to pregnant women for two
transmission years without boosting. Our goals are to further increase potency, increase efficiency
and consistency of manufacture and reduce cost of goods (COGS) to be able to use a PfSPZ vaccine
for elimination of malaria. PfSPZ vaccines are manufactured using stage V Pf gametocytes fed to
mosquitoes, a process that includes tight coordination between culture of gametocytes and mosquito
rearing. Most importantly, Sanaria has developed methods for producing PfSPZ without mosquitoes
in bioreactors (Nature, 2022). Transitioning to bioreactor production would increase efficiency of
manufacture by at least 10-fold, reduce COGS by >90%, and allow for PfSPZ vaccine production
worldwide. This proposal is intended to provide mass-produced, aseptic, purified, cryopreserved
ookinetes that can be used to increase efficiency of production of mosquito- and bioreactor-produced
PfSPZ vaccines. We will optimize production, purification, cryopreservation, QC release, and use in
manufacturing of ookinetes. The early steps in manufacturing that end with ookinetes can then be de-
linked from the later steps that commence with ookinetes, allowing both to proceed separately,
unconstrained by timing or physical location. The work will be addressed in 4 Specific Aims. 1:
Optimize ookinete production. Media and culture conditions for stage V gametocytes will be optimized
for conversion to ookinetes. Readouts will include female:male ratio, macrogametocyte density, and
stage specific antigen expression. Our target is a method that consistently results in 25% conversion
of stage V gametocytes to ookinetes. 2: Develop and optimize methods for ookinete purification. We
will test multiple methods, selecting those that can be scaled. Our target is Pf ookinetes that are
100% free of RBCs with a yield of 80% using a method that can be adapted to large scale
manufacturing. 3: Develop a protocol for ookinete cryopreservation. Sanaria routinely cryopreserves
PfSPZ with consistent, excellent results. Ookinetes are similar to PfSPZ. Both are motile, have a
multimembrane pellicular complex, express a dominant membrane protein, and are similar in size. A
range of cryoprotectant additives (CPA), cooling and warming rates, and CPA dilution methods will be
tested. Our target is a survival rate of at least 50%. 4: Develop assays for ookinete viability and
potency. 4 approaches will be tested: a) Membrane integrity, b) Motility, c) Infectivity to mosquitoes to
produce PfSPZ, and d) In vitro conversion of ookinetes to 3- and 8-day oocysts and iPfSPZ.

Public health relevance
PROJECT NARRATIVE The WHO has called for a malaria vaccine that is highly effective against parasite infection; Sanaria’s PfSPZ vaccines are the only candidates that have demonstrated the high efficacy needed to eliminate malaria by vaccination. PfSPZ vaccines are manufactured from live Plasmodium falciparum sporozoites (PfSPZ) currently in mosquitoes and in the future in vitro. We propose to de-couple the upstream stages of vaccine manufacturing by culturing Pf ookinetes in vitro, then purifying and cryopreserving the ookinetes prior to their use in PfSPZ vaccine production. With cryopreserved ookinetes that are viable upon thawing from stable storage conditions we will be able to initiate PfSPZ production campaigns without need for fresh blood and serum and gametocyte production currently needing ~30 days. Likewise, front-end manufacturing of PfSPZ in vitro will be highly standardized and the culturing time greatly reduced with the underlying aim of developing a scalable manufacturing schema.